Bayesian Statistical Learning for Robust and Generalizable Causal Inferences in Alzheimer Disease and Related Disorders Research

SUMMARY
To develop multi-faceted interventions for Alzheimer’s Disease and Related Disorders (ADRD) prevention, it
is key to quantify joint effects of environmental exposures throughout the life-span as well as the mechanisms
through which the exposures operate, which involve dynamic disease processes. These causal investigations
in observational studies face methodological challenges. This application, in response to PAR-22-093, will
accomplish the following goals: (1) develop robust Bayesian machine learning methods for causal mediation
analyses in life-course observational studies of ADRD; (2) apply these approaches in the analysis of two 30+
year cohort studies of Native Americans (Strong Heart Study) and of the Greater Boston area (Normative
Aging Study) to determine whether and to what extent the onset and severity of hypertension and
cardiovascular disease mediate the harmful effects of air pollution and heavy metals on ADRD; (3) develop
and disseminate computationally efficient and user-friendly software for widespread application of the methods.
The proposed work will address methodologic gaps in the causal investigation of health effects. First, no
mediation analyses approaches are available that simultaneously allow for multiple exposures and multiple
time-to-event and longitudinal mediators. Investigators can currently only build models that do not reflect real-
life conditions, considering a single exposure, or a single mediator producing segmented results, limited in
informing prevention. Second, most of observational studies in ADRD research are plagued by selection bias.
Participants may die before an ADRD diagnosis (attrition due to death) or may drop-out due to cognitive
impairment. Third, multicollinearity, skewness of exposures, complex exposure-response relationships and
time dependent confounding challenge valid estimation and inference. Fourth, no statistical approaches are
available to evaluate the generalizability of findings on determinants of and mechanisms leading to ADRD. We
propose to fill these gaps by developing and applying Bayesian machine learning approaches for quantifying
the total, direct and indirect effects of environmental and health factors on ADRD outcomes under the
counterfactual framework. We will develop and apply the new methods to estimate complex exposure-
response relationships of pollutants with time-to-event or longitudinal outcome potentially mediated by a single
time-to-event or longitudinal mediator (Aim 1), and mechanisms through multiple longitudinal and time-to-event
mediators (Aim 2). Furthermore, we will develop Bayesian data fusion algorithms to evaluate unmeasured
confounding bias and to generalize evidence from the study sample to the target population (Aim 3). In the
SHS and NAS we will investigate the role of hypertension and CVD trajectory, onset, and severity in mid and
late life as mediators of the neurotoxic effects of AP and metals. We will develop user-friendly and efficient R
packages that implement the proposed new methods. Our work has great potential to have broad impact on
life-course epidemiology research and prevention for ADRD and other chronic health outcomes.

Public health relevance
PROJECT NARRATIVE This project responds to the research need of more diverse cohorts, more participants, more variables, and more occasions of measurement to advance progress in the epidemiology of cognitive resilience and decline. We will develop advanced models for causal mediation analysis based on Bayesian machine learning approaches along with computationally efficient and user-friendly R packages to integrate rich longitudinal data on exposures and health markers and account for biases inherent in observational data from life-course studies. The proposed approaches will enable causal inference on joint exposure effects and time-to-event and longitudinal mediators to inform policy for environmental exposures and cardiovascular health in mid and late life to prevent Alzheimer’s Disease and Related Disorders in diverse populations.